SAFETY/EFFICACY OF RECOMBINANT HUMAN CILIARY NEUROTROPHIC FACTOR IN ALS

The purpose of this study is to determine the safety and efficacy of Recomb ant Human Ciliary Neurotrophic Factor (rHCNTF) in patients with Amyotrophic Lat al Sclerosis (ALS).